Program control of CD8+ T cell response to tumors and tumor memory

Abstract
CD8+ tumor infiltrating lymphocytes (TILs) are not only critical for the anti-tumor immune response in solid
tumors, but also in the success of adoptive cell therapies and in immune check point blockade (ICB) treatments.
CD8+ TILs have been shown to be heterogeneous, and in time to progress to a terminally exhausted state, with
no ability to respond, and resistant to reprograming by ICB. It remains of critical importance to understand the
biology, transcriptional programs and epigenetic control of the progression of the precursors, which have high
functional potential and stemness, to the terminally exhausted CD8+ TILs.
Cells with characteristics of memory have been identified in tumors and their presence is associated with
a positive outcome. Recently a memory CD8+ T cell population has been identified, located predominantly in
tumor draining LNs and showing an efficient antitumor response upon recall. However, little it is known about
tumor memory cells, their response, transcriptional and epigenetic control, as well as their failure in
recurrent tumors associated with relapse.
Our preliminary data show that ablation of the transcription factor BCL11B in TILs unleashes stemness at the
same time with the effector programs, but restricts exhaustion, providing TILs with increased ability to promote
a more efficient anti-tumor response compared to WT counterparts. In addition, depletion of BCL11B in TILs
from a patient who did not respond to TIL adoptive cell therapy, improved their cytolytic activity. We hypothesize
that BCL11B plays a central role in controlling essential programs of TILs, including stemness, effector and
exhaustion. Our preliminary data also show BCL11B KO tumor memory cells outperform WT memory
cells in a recall response to tumors.
Using scRNAseq and genome-wide histone marks analyses we will establish the programs and epigenomic
landscape controlled by BCL11B in mouse TILs. In addition, we will investigate the programs and the epigenomes
in melanoma TILs from responders and non-responders to TIL ACT, as well as from ovarian TILs form newly
diagnosed and recurrent ovarian cancer patients. We will determine the differences in their programs and
epigenome and the dependence on BCL11B, as well as the impact of BCL11B depletion on anti-tumor activity.
We will also investigate the heterogeneity and transcriptional programs of tumor memory cells, their dependence
on BCL11B and the behavior of the tumor memory cells in the recall response.
We will employ a multimodal integration strategy, to establish the pathways, the regulatory networks and
regulomes controlled by BCL11B in human and mouse TILs. Further the knowledge gained, including the
BCL11B KO signature and BCL11B regulatory networks, will be employed to predict the response to treatments,
including to ICB, and overall patient survival.

Public health relevance
This proposal investigates the transcriptional and epigenetic control of tumor infiltrating CD8+ T cells and of memory cells to tumors using mouse models and human cancer samples. Understanding the transcriptional and epigenetic control in such cells is essential in harnessing their therapeutic power for anti-tumor immune responses, including adoptive cell therapies, as well as for treatment predictions.